Development of 1,4-Benzodioxane Derivatives as F-18 PET Radiotracers for Alpha-2C Adrenergic Receptors and Their Preclinical Evaluations

PROJECT SUMMARY
Millions of middle-aged and seniors in the United States maintain their blood pressure and prevent
cardiovascular emergencies by taking - and -blockers daily. The total global market grew to $20 B for these
drugs in 2017. These two important drug classes commonly target adrenergic receptors (ARs) that execute
critical physiological functions such as respiration, digestion, circulation, emotion, memory, and cognition
mediated by norepinephrine (NE). Many - and -blockers bind nonspecifically to ARs and do not only produce
pharmaceutical effects but also accompany critical side effects. Therefore, subtype-selective AR agonists and
antagonists can achieve the desired goals without inducing the side effects. Such a request for the two drug
classes has been largely ignored. Among the nine subtypes of ARs, the biologic properties of 2C-ARs drew
interest in the pharmaceutical industry. The presynaptic 2C-ARs regulate the release of NE, dopamine, and
serotonin to the synapse. The brain 2C-ARs mainly concentrate in the limbic regions, such as the striatum and
hippocampus. Taking these properties together, the 2C-ARs can selectively control the neurotransmitter levels
in the limbic regions without affecting the levels in the prefrontal regions. Alzheimer’s disease (AD) features
neuronal loss in the hippocampus, where 2C-ARs are abundant and might be changed by the noradrenergic
neurons projected from locus coeruleus, the first brain system affected by AD. In substance use disorder (SUD),
activation of the 2C-ARs can reduce the neuronal hyperactivity in the limbic regions without affecting the brain
circuit toward the prefrontal cortex, which inhibits the instinctive behavior toward brain stimulants and facilitates
rational judgment against them. Therefore, 2C-ARs can be a good drug target, and their positron emission
tomography (PET) radiotracer can monitor their biological properties under various disease conditions.
[11C]ORM13070 is an important milestone because this is the first successful subtype-specific AR
radiotracer among their nine subtypes. However, its pharmacokinetic properties and specificities have to be
improved. The current project will develop the first fluorine-18 (F-18) 2C-AR radiotracers and evaluate them by
comparing their properties with [11C]ORM13070. We designed various 1,4-benzodioxane derivatives based on
ORM13070. The current strategy based on the existing molecular frame reduces the risk of failure and increases
the success of the development with short-term funding. The experience will eventually lead to future
development based on a new molecular framework. The current project selected seven candidate compounds
using a computer-aided docking model study. These compounds will be synthesized, and receptor-binding
assays will further select the compounds. After the target radiotracers are prepared, preclinical PET imaging
studies will evaluate them. The PET imaging data will also be validated by autoradiography and immunohistology.
The successful radiotracer can be patented for the application of diagnosis because Orion Pharma claimed them
only as drugs, and will be applied to SUD and AD preclinical imaging research.

Public health relevance
Project Narrative The recent development of [11C]ORM13070, a PET radioligand for 2C-adrenergic receptors (ARs), became a milestone for the development of subtype-specific drugs and radioligands for ARs, whose nonspecific drugs are consumed every day by middle-aged or older population worldwide to prevent cardiovascular emergencies and to manage their blood pressure, as strategies for reducing the dangerous cardiac and neuronal side effects of the nonspecific drugs for ARs. The localized distribution of 2C-ARs in the limbic regions of the brain and their presynaptic function as autoreceptors and heteroreceptors, which regulate the levels of norepinephrine, dopamine, and serotonin in the synapse, motivated us to develop more practical and useful F-18 PET radiotracers for 2C-ARs based on [11C]ORM13070 and to monitor the receptors in viable states to help set up the therapeutic strategy for 2C-ARs. This proposal will use a stepwise approach to synthesize seven 1,4- benzodioxane derivatives followed by receptor-binding assays for the in vitro screening, and the selected compounds will be prepared as F-18 radiotracers for preclinical PET imaging studies and autoradiography, which will be compared to immunohistochemistry work to validate the PET imaging data.